Clinical Core

The mission of the NIH-funded Atlanta Center for Microsystems Engineered POC Technologies (ACME POCT)
has been assist and enable inventors from across the country who have developed microsystems-based POC
technologies in defining their specific clinical needs, conducting clinical validation, and refining their technology,
with the objective of accelerating the path to translation and clinical adoption. The ACME POCT uniquely
leverages Atlanta's nationally top-ranked clinical programs at Emory University's hospitals and Children's
Healthcare of Atlanta, one of the nation's largest pediatric hospital systems, as well the internationally acclaimed
microsystems engineering expertise at Georgia Tech, which includes the Institute for Electronics and
Nanotechnology, and other one-of-a-kind medical device prototyping, innovation, and testbed facilities. As the
COVID-19 pandemic emerged, the ACME POCT served as the national Test Verification Core for the NIH's
Rapid Acceleration of Diagnostics (RADx) initiative to assess, validate, and scale-up production of POC COVID-
19 diagnostics for the entire country, and with the enhanced experience and expertise our Center attained within
that role, the ACME POCT is now especially well positioned to address those issues and apply our lessons
learned from RADx towards assisting any and all microsystems POC diagnostics for any and all clinical
applications.